Epidemiology & Cancer Control (ECC) Research Program

PROJECT SUMMARY/ABSTRACT
The vision of the Epidemiology and Cancer Control Program (ECC) is to reduce the cancer burden in the
PCC catchment area and beyond. To achieve this vision, we conduct innovative and high impact research,
discovering risk factors and translating this knowledge into effective cancer control. Under the continued
leadership of Jiyoung Ahn, PhD and new Co-Leader Danil Makarov, MD, MHS, ECC organizes its research
efforts into four complementary thematic aims: Aim1: To discover and effectively modulate cancer-causing
microbial and genetic risk factors, Aim 2: To assess and effectively control cancer-causing environmental and
behavioral risk factors, and Aim 3: To improve cancer care delivery by identifying and disseminating best
practices across the care continuum. The Program is composed of 37 full members from 15 academic
departments in the NYU Grossman School of Medicine (NYUGSoM), particularly the Department of Population
Health, as well as the NYU College of Nursing, College of Dentistry, and College of Global Public Health. ECC
members currently have 76 funded projects totaling $13.1M in annual direct costs, $5.5M from NCI (43% of peer-
reviewed funding). Our members are highly collaborative, as indicated by 34% intra- and 21% inter-programmatic
collaborations, 52% inter-institutional collaborations (with other NCI-CCs), and 32 multi-PI grants. Program
members published 858 papers in the current period, including many in top tier journals, such as NEJM, Lancet,
and JAMA Pediatrics (19% of publications [n=163] have IF>10). Our signature research on the microbiome has
led to novel discoveries of cancer-causing microbial risk factors, published in JAMA Oncology, Gut, JNCI and
already cited more than 250 times; these paradigm-shifting hypotheses on microbial contribution to these
malignancies have also fueled translation to clinical trials and stimulated new avenues of basic science research.
Our work on developing innovative smoking control methods and assessing air pollution—cancer risk
relationships impacted major health policy locally in our catchment area and nationally. Our health services
research, including studies of optimized imaging use and active surveillance, helped inform standard guidelines of
care for prostate cancer patients. ECC has continued to make exceptionally high impact scientific contributions,
with particular attention to the needs of our unique catchment area.